Mechanisms of immune evasion in T-cell acute lymphoblastic leukemia and its therapeutic implications

Project Summary
T-cell acute lymphoblastic leukemia (T-ALL) is an aggressive hematopoietic malignancy in children and young
adults that frequently becomes treatment-refractory and relapses. Although cure rates have improved with
intensified multi-agent chemotherapy, relapsed or treatment refractory disease remains very difficult to treat.
Therefore, there is a great medical need for identifying novel vulnerabilities and therapeutic approaches.
Targeting of the immunosuppressive tumor microenvironment has led to promising results in many solid tumors.
Yet, comprehensive studies of the T-ALL microenvironment, which are necessary to characterize
leukemia/immune cell interactions and identify therapeutic vulnerabilities, have not been performed. Using single
cell sequencing technologies of T-ALL blasts and their microenvironmental cells, we have generated preliminary
data suggesting a novel role of immune evasion in T-ALL with the potential to incorporate immunotherapy
approaches into current treatment regimens to overcome T-cell exhaustion. This proposal seeks to define novel
mechanisms of immune evasion in T-ALL and develop means for their therapeutic targeting. We will define
mechanisms of CD8+ T-cell dysfunction by combining RNA-Seq, immune repertoire and protein analysis in single
leukemia and microenvironmental cells in primary T-ALL patient samples and determine the necessary and
sufficient exhaustion receptor/ligands through functional perturbation in in vitro and in vivo models of T-ALL (aim
1); We will study epigenetic and transcriptional mechanisms that regulate immune evasion in T-ALL and develop
novel strategies to target T-cell dysfunction in pediatric leukemias by perturbing the epigenetic machinery (aim
2). Successful completion of this proposal is expected to uncover novel mechanisms of immune evasion in T-
ALL and will lead to development of innovative therapeutic strategies for targeting T-cell exhaustion in the
immune microenvironment in patients with high-risk T-ALL. The principles described in T-ALL will have a
significant impact on a wide variety of malignancies.

Public health relevance
Project Narrative T-cell acute lymphoblastic leukemia (T-ALL) is an aggressive hematopoietic malignancy in children and young adults that frequently becomes treatment-refractory and relapses. This project seeks to define novel mechanisms of immune evasion in T-ALL. It will lead to development of novel and transformative therapeutic strategies through targeting T-cell exhaustion for patients with high-risk T-ALL.